Core-002

Our overall vision is to develop, demonstrate, and disseminate innovative programs to achieve translational success and to integrate these into a seamless “Learning Clinical Research Enterprise” that uses outcome data to drive continuous quality improvement for the benefit of human health. To achieve this goal, the Rockefeller Center for Clinical and Translational Science (CCTS) will integrate diverse communities, including minority and underserved populations, into our translational research enterprise, and will engage community clinicians in the process by building collaborative research teams. We will also rapidly disseminate information about our programs to the CTSA community. Our specific aims are: 1) To build transdisciplinary collaborative research teams that: a) insure that community clinicians and patients participate in setting the priorities for research studies, and in study design, conduct, dissemination, as well as implementation; b) maximize the synergies that come from integrating the full range of translational research extending across epidemiology and health policy to basic mechanistic research; 2) To incentivize, recognize, and reward team science by: a) providing resources for team science approaches through Pilot project funding and support of Clinical Scholars, b) academic promotion policies that reward collaborative contributions, c) designing and providing a career development pathway for community clinicians to train as clinician scientists and insuring recognition in public presentations and authorship, d) supporting a robust suite of scientific core facilities led by team scientist leaders; and 3) To obtain outcome data related to community engaged research and team science to drive continuous performance improvement as part of the “Learning Clinical Research Enterprise.” We will accomplish these aims by building on our: 1) Community Engaged Research Navigation (CEnR-Nav) Program, which helps investigators develop partnerships with community patients and clinicians, 2) maintaining a strong, bi-directional partnership with Clinical Directors Network (CDN), a practice based research network serving minority and underserved populations, through which we have developed innovative programs to foster development of sustainable partnerships between investigators and community stakeholders, 3) supporting a Mutually Aligned Community Engagement/Mechanistic Science (MACEMS) Program, which engages laboratory investigators in community-engaged research, creates multidisciplinary project-specific research teams that represent a full range of patient and community stakeholders, and ensures the opportunity to advance the mechanistic understanding of the clinical observations, 4) introducing a new Translational Research Navigation Program which will integrate the CEnR Nav and MACEMS programs into an overarching team science structure that facilitates protocols throughout their lifespan, from concept through dissemination.